Intellectual and Developmental Disabilities Research Centers

PROJECT SUMMARY/ABSTRACT
This P50 award will continue to support the Intellectual and Developmental Disabilities Research Center
(IDDRC), which has been central to the scientific enterprise at the Kennedy Krieger Institute (KKI) and Johns
Hopkins University (JHU) for over 30 years—supporting investigators seeking to understand, treat and
ameliorate the adverse impact of intellectual and developmental disabilities (IDD), and to disseminate
discoveries to the public toward a goal of prevention. The IDDRC continues to be structured around five Cores:
(1) Administrative; (2) Clinical Translational; (3) Genomics; (4) Neuroimaging; and, (5) Behavioral Phenotyping,
as well an integrated Research Project examining the role of sleep, circadian dysfunction, and brain
development in children with autism.
The Center's organization and Core structure are aligned with the research priorities of the NICHD IDD
branch, including understanding etiology and complex comorbidities of IDD; improving early identification and
screening; identification of biomarkers and outcome measures; understanding natural history; and translation
of discovery to treatment and, ultimately, to public policy—all with a goal of prevention. The Center's
translational science theme centers on progressing knowledge along the continuum from “labs to clinics to
communities.” In keeping with these goals, this Center's aims promote translational science along the full
continuum of T4 translation. This emphasis is employed throughout the Center, with added importance on
dissemination through the Administrative Core via links to the Institute's UCEDD (Maryland Center for
Developmental Disabilities) and Leadership Education in Neurodevelopmental Disabilities (LEND) programs.
The Center's aims are to: (1) provide infrastructure, expertise, and services necessary to promote and
facilitate interdisciplinary research in the field of IDD; (2) act as the vehicle through which inter-institutional
partnerships (including inter-IDDRC partnerships) addressing IDD research are developed and implemented;
(3) provide training and technical assistance opportunities related to scientific inquiry within the field of IDD;
and (4) serve as a hub (both locally and nationally) for translation and dissemination of scientific discoveries
related to IDD toward the goal of informing (and ultimately shaping) public policy.

Public health relevance
PROJECT NARRATIVE This award will continue supporting activities of the longstanding Intellectual and Developmental Disabilities Research Center (IDDRC) at the Kennedy Krieger Institute and Johns Hopkins University. The IDDRC's primary goals focus on supporting actively funded research projects targeting intellectual and developmental disorders (IDD) through Cores (Administrative, Clinical Translational Research, Genomics, Neuroimaging, and Behavioral Phenotyping). In addition, the Center directly supports a research project examining the role of sleep, circadian dysfunction, and brain development in children with autism.